Causal mediation analysis in mental health with mediator missingness

PROJECT SUMMARY
Examining the mechanisms behind exposures and interventions is crucial in mental health
research; doing so can help identify potential intervention targets and tailor interventions to
optimize outcomes. Causal mediation analysis is an important tool for this job. An important but
under-appreciated challenge in mediation analysis is missing data. Missing data are ubiquitous
(even in high quality mental health studies) and are more of a challenge in mediation analyses
than in standard analyses, due to the involvement of more variables. Missingness tends to be
worse when the analysis involves multiple mediators and/or when data collection at intermediate
time points (when mediators are measured) receives less attention than baseline and outcome
data collection. Since most methodological work assumes complete data, it is not yet well
understood how to appropriately handle missing data when conducting causal mediation
analysis. As the first step in removing this barrier to effective use of causal mediation analysis in
mental health researcher, this project will tackle the problem of mediator missingness, a
common problem in practice and a particularly important one to tackle for the validity of
mediation analyses. This project will develop two classes of methods for this purpose: (1) with
the estimating equations approach, we will transform each of a collection of full-data methods to
observed-data methods that are doubly robust – consistent if either a missingness model or a
model for some relevant function of the mediator given observed data is correct; (2) to respond
to the popularity of multiple imputation, based on each full-data method, we will develop
targeted multiple imputation procedures tailored to the method and the effects being estimated,
to minimize bias due to misspecification of the imputation model. The project seeks methods
that can be explained intuitively, and will pay special attention to communicating and
disseminating the methods developed to mental health researchers. For illustration, the
methods will be applied to an analysis of effects of a treatment for anxiety disorder and an
analysis of disparities in suicidality affecting sexual minority youth.

Public health relevance
PROJECT NARRATIVE Examining effect mechanisms of exposures and interventions is crucial for understanding and developing treatments and interventions to improve mental health; and causal mediation analysis is a state-of-the-art tool for this job. While mediation analyses are affected by missing data to a greater degree than standard analyses, it is not yet well understood how to appropriately handle missing data in causal mediation analysis, as research on this topic is extremely limited. Taking an important step toward removing this barrier, this project will develop rigorous and intuitive methods to handle mediator missingness (a common problem and an important threat to validity) in causal mediation analysis, in order to facilitate sound analyses of mechanisms in mental health research.